Mechanism of white matter pathology in Alzheimer's disease

PROJECT SUMMARY
Myelin degeneration and white matter loss that result from oligodendrocyte (OL) death are early events in
Alzheimer’s disease (AD) that lead to cognitive deficits and correlate with disease status. The loss of OLs,
accompanied by a reduction of myelin density, axonal loss, and astrogliosis, are major changes in white matter
that occur in the brains in both AD patients and animal models of AD. OLs are the most abundant glial cell type
in the brain but the least studied cell population in the context of neurodegeneration, despite their vital role in
myelin maintenance and neuronal support. Recent genome-wide association studies and large-scale single-
cell transcriptomics of AD patient brains emphasized the crucial role of OLs in the development of AD. The
underlying mechanisms of OL dysfunction and its contribution to the initiation and progression of AD remain
unknown. Our recent work reports, for the first time, that mature OLs in AD patients and AD mice exhibit
NLRP3 inflammasome-associated inflammatory injury, concomitant with demyelination and axonal
degeneration. Unbiased proteomic analysis further suggests that the hexokinase 1 (HK1)-dependent glycolysis
pathway is most suppressed in AD mouse white matter. Mature OLs rely heavily on glycolysis for energy
production, even in the presence of oxygen. HK is the rate-limiting enzyme that initiates the first step of
glycolysis by the phosphorylation of glucose. OLs specifically express a brain HK isoform, HK1. HK1 localizes
to the mitochondrial outer membrane, and the dissociation of HK1 from mitochondria decreases its enzymatic
activity, which is sufficient to inhibit glycolysis and induce NLRP3 inflammasome activation. We found that HK1
immunodensity and enzyme activity significantly decreased in OLs in AD patients and AD mice. In mature OLs
in AD, the HK1 mitochondrial association is disrupted by overactivation of the mitochondrial fission protein
dynamin-related protein 1 (Drp1), and Drp1 and HK1 synergistically elicit NLRP3 inflammasome activation and
the release of interleukin-1β, triggering inflammation. The mature OL-specific heterozygous knockout of Drp1
in AD mice restores HK1-dependent glycolysis, abolishes NLRP3 inflammasome activation, corrects myelin
loss, reduces neuroinflammation and axonal degeneration, and improves cognitive function in animals. These
findings support the scientific premise of the proposed project that glycolytic deficiency in OLs, driven by the
Drp1-HK1 molecular switch, induces OL metabolic dysregulation and inflammation and causes white matter
degeneration, AD pathology, and cognitive impairment. Successful completion of the proposed studies will
support the hypothesis that OL metabolic deficiency is a key pathological process that induces inflammation,
demyelination, white matter loss, and AD-associated neuropathology and cognitive deficits. These studies are
crucial to further reveal the role of the novel Drp1-HK1 OL pathway in AD and determine whether this
pathological pathway is a plausible treatment target for AD.

Public health relevance
Project Narrative Alzheimer's disease (AD) is the most common age-dependent neurodegenerative disorder, for which there is no effective treatment. The proposed study seeks to better understand the molecular mechanisms by which signals induce AD-associated neuropathology via regulation of oligodendrocyte metabolism and to reveal novel targets for developing therapeutics to treat AD.